Contribution of Phosphate to Inflammatory Bone Loss

Project Summary/Abstract
Objectives: The median age of veterans in 2018 was 65 and women make up the fastest growing share of
veterans, estimated at 17% by 2040 (American Community Survey). Almost 25% are over 75 years old and
68% are 55 and older. Aging is associated with an increased vulnerability to a number of diseases including
osteoporosis with the associated increased risk of fracture. Fractures have serious health consequences
including lengthy rehabilitation and the most serious, hip fractures, may cause prolonged or permanent
disability and almost always require hospitalization and major surgery. A recent retrospective, secondary
analysis of National Veterans Health Administration Medicare beneficiaries concluded that one in three elderly
male veterans who sustain a hip fracture die within one year. Another retrospective study of 41,331 veterans
determined that approximately 18.3% of hip fracture patients were readmitted within 30 days and of those
48.5% died within one year. Therefore, prevention of fractures would represent a significant health intervention,
improving longevity as well as quality of life in the veteran population. Nutritional intervention as a means to
modulate health and disease represents a promising area of opportunity to improve health although sufficient
data does not currently exist to optimally take advantage of this strategy.
Research Plan: We have identified inorganic phosphate that is consumed in great excess by Americans as a
nutritional element that strongly influences inflammation and bone quality and might be manipulated for
improvement of bone mass and quality. Therefore, the goals of this study are to further investigate the value of
controlling phosphate intake for the improvement of bone quality and reduction of inflammation. Our published
and preliminary data strongly support the working model and hypothesis that high dietary Pi intake results in
changes in the microbiome, compromised intestinal integrity, and chronic inflammation leading to bone loss,
while a reduced Pi diet is beneficial to bone volume and reduces inflammation. Growing evidence strongly
suggests that the gut microbiota can have profound systemic influence on health and disease although the
details are only beginning to be uncovered. How, individual environmental elements such as nutrients alter the
gut microbiota is even less understood. Pi is required for cell and bacterial growth and excess Pi is known to
positively influence cell growth, and in some cases cause deregulated growth, leading to our general
hypothesis that a sustained high Pi diet results in changes to the microbiome composition which results in
inflammation and bone loss.
Methods: Proposed studies will utilize a comprehensive series of innovative mouse models including Germ-
Free, antibiotic treated, and T cell tracking mice to; 1) To determine if a sustained high phosphate diet
generates increased intestinal inflammation, 2) To identify the mechanisms whereby the gut microbiome
influences high dietary phosphate-induced bone loss including intestinal permeability and changes in
microbiome content, and 3) To determine if the microbiome can be manipulated to modulate Pi homeostasis
and bone metabolism.
Clinical Relevance: Prevention of fractures will greatly reduce both the personal and financial burden to
veterans relative to post-fracture treatment. These studies will be the first to investigate the effect of the
common nutritional element particularly relevant to the dietary habits of Americans in Pi on gut inflammation
and long-term changes to the gut microbiome. Results could unveil new clinically relevant prevention strategies
to modulate mineral homeostasis that have broad consequences on health and disease.

Public health relevance
Project Narrative The average age of veterans is increasing and therefore understanding the underlying etiology of age associated disease vulnerability, as well as establishing new prevention and therapeutic strategies is of significant importance. Aging is associated with an increased susceptibility to a number of diseases including osteoporosis with its associated increased risk of fracture. Our studies aim to address improving bone health and healing by nutritional prevention strategies as well as proactive therapeutic interventions to manipulate the microbiome. We will use a comprehensive series of innovative methodologies to investigate the novel concept that the microbiome is integral to dietary Pi sensing and can alter disease pathology associated with sustained high Pi consumption including chronic inflammation and bone health. The studies proposed herein could open numerous new avenues to identify novel strategies to influence veterans' health as they age.